Acid Spingomyelinase as a Target in Metabolic Syndrome-Exacerbated Periodontitis

Project Description
Periodontitis is a disease of the supporting structures of the teeth, characterized by tissue inflammation and
destruction. While periodontitis is initiated by periodontal pathogens, diabetes and metabolic syndrome
(MetS), which is considered as prediabetes, aggravate its progression. The finding that MetS exacerbates
periodontitis is of importance because about 34% of adult Americans have MetS. However, the mechanisms
whereby MetS interacts with periodontal pathogens to aggravate periodontitis remain largely unknown. To
better study the interaction between MetS and periodontitis, we successfully developed a mouse model with
periodontitis and high-fat diet (HFD)-induced MetS to demonstrate that MetS is associated with increased
periodontal tissue inflammation and alveolar bone loss. Since the HFD is enriched in saturated fatty acid
(SFA), which is increased in the plasma of patients with MetS, we tested our hypothesis that SFA boosts
macrophage inflammatory response triggered by periodontal pathogen-derived virulence factors such as
lipopolysaccharide (LPS). Results showed that palmitic acid (PA), the most abundant SFA, amplifies LPS-
induced inflammatory cytokine expression in macrophages by 3-4 folds. More interestingly, we found that acid
sphingomyelinase (ASMase)-mediated sphingomyelin hydrolysis and resulting increased ceramide (CER)
production (ASMase-CER pathway) plays a key role in the upregulation of inflammatory cytokines by PA and
LPS. Based on our above findings and the notions from the literature that CER and its downstream products
such as sphingosine-1-phosphate play a vital role in many pathobiological processes such as inflammation,
proliferation and apoptosis, we proposed this study with the following 3 specific aims: 1. To determine the role
of ASMase in periodontal inflammation and alveolar bone loss in mice with or without MetS. We hypothesized
that ASMase is a potential target to reduce MetS-related alveolar bone loss. 2. To determine the role of
ASMase in the stimulation of osteoclast formation and fibroblast apoptosis by LPS and PA. We hypothesized
that ASMase-CER pathway mediates the stimulatory actions of LPS and PA on osteoclast formation by
enhancing RANKL-RANK interaction and on fibroblast apoptosis by increasing release of macrophage-derived
pro-apoptotic cytokines. 3. To determine the mechanisms by which ASMase-CER pathway mediates PA-
amplified TLR4 signaling in macrophages. We hypothesized that ASMase-CER pathway mediates the
stimulation by LPS and PA of NFκB signaling via CD36/MyD88-independent pathway and inflammasome.

Public health relevance
Project Narrative: Periodontitis, an oral disease characterized by periodontal inflammation and alveolar bone loss, is aggravated by systemic disease such as diabetes and metabolic syndrome (MetS). In this study, we will test our hypothesis that targeting acid sphingomyelinase (ASMase) to reduce ceramide (CER) generation is associated with an improvement of periodontal tissue inflammation and alveolar bone loss in mice with or without MetS. We will also investigate the mechanisms whereby ASMase-CER pathway mediates osteoclastogenesis, apoptosis and inflammatory signaling.